Bioinformatics/data science Core (BDSC)

The Bioinformatics and Data Science Core (BDSC) aims to advance the study of
temporomandibular disorders (TMDs) through a modern data-driven framework that combines
traditional statistical models with artificial intelligence (AI) methods and an ontology-based
approach to ensure data interoperability across multi-site studies. Ontology, in this context,
refers to a formally structured system that defines key terms and relationships within a specific
domain, enabling consistent tagging and integration of data from diverse sources. By
addressing the challenges of inconsistent diagnostic and treatment models within the dental
field, the BDSC seeks to provide a unified structure for understanding TMDs and develop
analytic pipelines for deep phenotyping, enabling reliable identification of TMD subtypes.
Leveraging findings from the OPPERA study, the Core will explore existing TMD datasets and
integrate neuroinformatics to examine multimodal brain imaging alongside clinical data,
uncovering neurobiological mechanisms underlying these conditions. Ontologies will play a
central role in promoting semantic interoperability, improving the use of common data elements,
complementing statistical analyses, and facilitating the integration of data across the
Collaborative. The BDSC will support the CREATE Center and the TMD IMPACT Collaborative
by offering data analysis resources, applying ontologies to complex datasets, and providing
consultation services to investigators and trainees. This initiative, aligned with the NIH directive
to reevaluate TMDs beyond traditional assumptions, seeks to uncover new insights into the
etiology, mechanisms, and treatment of TMDs while addressing their broader context within
chronic overlapping pain conditions (COPCs).